De novo design of functional metallocofactor-binding proteins

Project Summary/Abstract
Metalloproteins perform chemical transformations with rates and selectivites that have yet to be achieved in
synthetic or designed systems. These differences in reactivity are directly linked to the environment produced
by the protein matrix. To test our understanding of how metalloproteins function, I aim to design de novo
metalloenzymes from scratch. Proteins that bind porphyrin-like cofactors are of particular interest, as heme
proteins are known to perform a variety of reactions. Recently, I designed a protein to bind the abiological
porphyrin, Mn-diphenylporphyrin (MnDPP), that provided the first crystallographic structure of a de novo
designed porphyrin-binding protein (MPP1). MPP1 was also capable of stabilizing a Mn(V)-oxo species, a
powerful oxidant that can perform sulfoxidation of thioether substrates. The proposed research seeks to
elucidate design features necessary to control the reactivity/stability of this high-valent species through
rational mutagenesis of my designed protein. This will allow direct correlation of changes in reactivity to
changes in structure. To gain greater control of substrate orientation and, therefore, product distribution, I will
design a 5-helix bundle that has a large pocket for substrate binding. Using the design strategy for MPP1 and
in-house developed computational methods, the 5-helix bundle will be parameterized from scratch and
designed to bind MnDPP. A library of sequences will be expressed and screened using high-throughput
methods for binding and sulfoxidation activity. Promising scaffolds will then be redesigned to include
substrate-specific interactions to bind the anti-inflammatory drug, diclofenac. Using COMBS, a recently
developed bioinformatics method for designing backbone specific polar interactions, I will design two proteins
to control the orientation of diclofenac to direct the hydroxylation to yield 5-hydroxydiclofenac or 4’-
hydroxydiclofenac. This work would be a breakthrough in protein design and will directly impact the
fundamental understanding of the effects of protein environments on the function of metal centers in
metalloproteins.

Public health relevance
Project Narrative Metalloproteins perform a wide range of chemical transformations whose functions are imperative for maintaining human health. The entire protein scaffold that houses the metallocofactor is responsible for controlling active site geometry, electronic structure of the metal center, reaction pathway, and substrate specificity. The ability to design proteins from scratch that bind metallocofactors and control substrate orientation will establish key structure-function relationships that govern the function and selectivity of efficient metalloenzymes.